Robotically-actuated, low-noise, concurrent TMS-EEG-fMRI system

Abstract
The ability to noninvasively modulate and image the brain with spatial and temporal precision is highly desirable
for understanding brain circuits in health and disease. Transcranial magnetic stimulation (TMS) is a method for
stimulating the superficial cortex with high spatial and temporal precision, and its effects can be aimed at deeper
targets by leveraging the trans-synaptic connectivity of brain circuits. Functional magnetic resonance imaging
(fMRI) has high spatial resolution but limited temporal precision, and the opposite holds for
electroencephalography (EEG). These three noninvasive electromagnetic methods have recently been
combined to achieve high spatial and temporal precision of concurrent modulation and imaging of the brain. This
approach, however, has various significant technical limitations, including mutual electromagnetic artifacts
decreasing the signal-to-noise ratio and delaying the acquisition of imaging/EEG data, TMS acoustic noise co-
activating auditory pathways, and the inability to adaptively adjust the TMS coil position within the MRI scanner
for optimal targeting. The overarching objective of this project is to address these limitations by developing and
integrating an array of novel technologies. We will develop a compact, energy efficient, quiet, as well as MRI-
and EEG-compatible TMS coil. The TMS coil will be actuated with a custom MRI-compatible robotic system,
allowing adaptive optimization of the coil position and orientation based on imaging feedback. The neural circuit
responses to the stimulation will be imaged with a newly developed a flexible, head-conforming array of MRI
coils combining local magnetic field shimming and RF receiving to achieve high signal-to-noise ratio and fast
image acquisition. The brain activity will be simultaneously recorded both before and after TMS with high
temporal resolution and low noise using a novel wireless EEG system. To meet the technical challenges of
creating such as a system operating inside MRI scanners, our team has developed several breakthrough
technologies that will work synergistically to reduce or eliminate couplings between system components and
enhance the stimulation precision and imaging speed and sensitivity. Once developed, the robotically-actuated
TMS-EEG-fMRI system will enable systematic interrogation of human brain circuits inside an MRI scanner with
spatial and temporal flexibility and precision that are impossible to achieve with current technology. The
integrated system will be easy-to-use, and platform-agonistic thus having the potential for immediate and
scalable impact. First-time adaptive optimization of the TMS coil placement in the MRI scanner will be
demonstrated for brain-state-triggered engagement of a deep brain target. In summary, the proposed robotically-
actuated TMS-EEG-fMRI system will enable modulation and imaging of brain circuits with enhanced anatomical
and functional precision that can lead to advances in neuroscience research and therapeutic interventions.

Public health relevance
Project Narrative The overarching objective of this project is to enable multimodal noninvasive stimulation and recording of human brain circuits with high anatomical and temporal precision. The project is to create a closed-loop brain interface that integrates simultaneous neural recording and high-fidelity MRI acquisition with steerable transcranial stimulation. The proposed brain interface is a new noninvasive tool for studying human brain circuits in vivo and for therapeutic interventions.